Explorative studies of novel IgE ligands

Project Summary Most allergic reactions are caused by immunoglobulin E (IgE) antibodies that are specific for allergens and that trigger potent inflammatory responses mediated by mast cells and basophils. IgE binds to the high affinity receptor (FcεRI) expressed on these allergic effector cells, making this a central interaction that is common to different allergen-specific responses. The anti-IgE antibody (omalizumab) is currently used to treat allergic asthma and chronic idiopathic urticaria, demonstrating the feasibility of inhibiting the IgE:FcεRI interaction for therapeutic benefit. We have developed multiple approaches to identifying small molecule ligands for the IgE and identified promising leads for further studies. In this proposal, we will further investigate these leads to explore the possibility of producing novel probes for IgE function and inhibition. !

Public health relevance
Project Narrative IgE antibodies play a central role in the majority of allergic responses, binding to a high affinity receptor on mast cells and basophils and priming these effector cells to respond to allergens. In this proposal we will study the interactions of IgE with small molecules to develop novel probes or inhibitors that could be of scientific, diagnostic or therapeutic use. The identification of small molecule inhibitors of the IgE:receptor interaction would represent a major breakthrough in allergy treatment, potentially allowing oral or aerosol delivery to replace anti-IgE injections or other therapies aimed at downstream symptoms of mast cell and basophil activation.